Career Development Program

The future development and dissemination of molecular imaging research depends on the availability of scientists who are well grounded not only in their basic discipline, but also in translational aspects of cancer research. The overall goal of the Career Development Program of this P50 has been to provide broad multidisciplinary training for two junior investigators per year who have an outstanding academic track record and who wish to change research directions and/or who need additional time in a productive scientific environment to establish an independent research program. The program emphasizes the education of basic (PhD) and clinical (MD or MD/PhD) scientists in the principles and applications of molecular imaging techniques to answer basic science or clinical questions through in vivo imaging. The program consists of multidisciplinary training by senior preceptors, didactic lectures individual research projects and design of hypothesis driven research, publication and grant writing. The specific aims of the Program are: 1. Recruit two outstanding junior faculty per year from a larger applicant pool 2. Provide broad training and research support to the above individuals 3. Promote excellence in science and medicine